Engineering cell-based therapy for enhanced survival and durable function in vivo

Project Summary
The long-term goal of my lab is to develop durable cell-based therapies for treating various chronic diseases.
Engineered cells secreting therapeutic proteins are grafted into the body to act as biological drug-factories and
provide an attractive strategy for long-term cure of diseases such as hemophilia, diabetes, and liver disorders.
‘Off-the-shelf’ therapeutic cells are immunogenic to the host and must be protected from the host immune
system. Cell-encapsulation systems physically isolates the graft from components of the host immune system
and provide a safe and effective way to transplant allogenic cells without systemic immunosuppression.
Unfortunately, despite decades of intense research, the goal of developing an encapsulated cell-based therapy
that remains functional in humans long-term has yet to be realized. Two core challenges to the proper function
of encapsulated cells in vivo are 1) Activation of the host immune system (innate and adaptive) resulting in
foreign-body reactions (FBR) to the implant leading to fibrosis and cell death, and 2) cellular dysfunction and
death due to hypoxic and pro-inflammatory environments. Research efforts to combat these challenges have
primarily focused on material innovation, while very little attention has been given to engineering cells and system
that function synchronously. The changes in cellular processes within the graft in vivo and how the graft interacts
with the host immune system remain a black box. Over the next five years, my lab’s research will aim to fill this
knowledge gap in our understanding of cellular behavior in vivo and engineer cells and systems that are designed
to survive and function within the body for long periods. We hypothesize that by systematically engineering the
cellular hosts and the encapsulation system, we will be able to improve efficacy, extend the lifetime, and expand
the range of applications of cell-based therapies. To do this, we will pursue three independent research
directions, which can be synergistically combined to derive superior cell therapy products. First, we will uncover
pathways responsible for the death and dysfunction of transplanted cells allowing us to engineer resilient cells
suitable for long-term survival in vivo. Next, we will engineer stealth by reducing the immunogenicity of the
implant and presenting tolerogenic cues to the host immune system. Finally, we aim to build function into these
implants by incorporating advanced features to allow the retention of these devices on soft organs such as the
liver and heart. Given the broad challenges presented by encapsulated cell systems in vivo, these future efforts
are well-suited to the research program, as they utilize a widely applicable multiscale and multi-disciplinary
experimental framework.

Public health relevance
PROJECT NARRATIVE Off-the-shelf engineered cells secreting therapeutic proteins is an attractive approach for treating chronic diseases such as hemophilia, diabetes, and liver disorders. However, poor survival and dysfunction within the in vivo environment limit their clinical translation. My lab will use bioengineering strategies to design cells and implants better suited for long-term survival and durable functioning at the target organ in vivo.